Role of the innate immune system in acute kidney injury

Following the immediate injury to intrinsic kidney cells induced by ischemia/reperfusion, we and others
have demonstrated an important role for innate immune cells in both propagation of injury and subsequent
recovery. There is an initial renal influx of neutrophils after ischemic injury, followed a few hours later by
accumulation of proinflammatory monocytes and activation of resident renal macrophages. Within days after
the injury, the majority of renal macrophages shift from a proinflammatory to an anti-inflammatory and pro-
resolution phenotype, which is essential for effective repair and resolution of the injury. Meanwhile, with
moderate ischemic injury, neutrophil numbers in the injured kidney progressively decrease, and relatively few
neutrophils remain after 72 hours. Although neutrophil apoptosis and efferocytosis by macrophages is an
important mechanism of neutrophil clearance, in addition, in other tissues, studies have shown that intact
neutrophils may also exit the tissue through “reverse migration”. Mechanisms underlying the resolution of
inflammation are an area of active investigation. The question of what mediates resolution of inflammation, and
specifically what mediates the resolution of the inflammation resulting from ischemic AKI, remains unresolved.
Cyclooxygenase (COX) is the rate-limiting enzyme that metabolizes arachidonic acid to prostaglandin G2 and
subsequently to prostaglandin H2, thereby serving as the precursor for subsequent metabolism by
prostaglandin synthases. More than 20 years ago, Gilroy et al. reported a paradox in sterile inflammation.
Pharmacologic COX-2 inhibition at the early phase (2h) accelerated recovery while the same pharmacologic
inhibition prevented recovery when applied 24h later, suggesting that COX-2 may have different roles in
neutrophils and macrophages in inflammation resolution.
We have recently we have reported that COX-2 expression increased in renal macrophages following
ischemic injury, and selective deletion of COX-2 or the PGE2 receptor subtype 4 (EP4) with myeloid-specific
Cre recombinases delayed recovery, resulting in persistent inflammation in the post-ischemic kidney and
subsequent tubulointerstitial fibrosis. In our new preliminary results, we now surprisingly find that selective
deletion of neutrophil COX-2 expression results in decreased injury in response to an ischemic insult. We
propose that the macrophage COX-2/PGE2 axis promotes recovery from AKI, but the neutrophil COX-2/PGE2
axis has the opposite effect and is important for the initial injury induced by neutrophil infiltration. The goal of
our proposed studies is to further our understanding of mechanisms of resolution from AKI by characterizing the
disparate roles and mechanisms played by the COX-2/prostaglandin system in neutrophils and macrophages
following acute ischemic kidney injury. We have two specific aims:
Specific Aim 1 Determine the role of the macrophage COX-2-PGE2-axis in recovery from ischemic AKI
Specific Aim 2 Determine the role of COX-2 in neutrophil function in response to ischemic AKI

Public health relevance
The proposed studies will investigate the role of a cyclooxygenase-2/PGE2 axis to mediate macrophage and neutrophil responses to acute ischemic kidney injury. The studies will investigate mechanisms by which innate immune cells interact to exacerbate acute kidney injury and the mechanisms by which they mediate regeneration of the intrinsic kidney cells.